MKP5 allostery in MAPK regulation and signaling in the heart

ABSTRACT
The catalytic activity and specificity of the mitogen-activated protein kinase (MAPK) phosphatases (MKPs) is
governed through their ability to interact with the MAPKs. The MKPs set the fidelity and kinetics of MAPK
signaling by regulating, in a spatially distinct manner, both the magnitude and duration of MAPK activity.
However, these regulatory mechanisms alone are insufficient to explain the complexity of MKP/MAPK-
mediated signaling. This is exemplified by the observation that inactivation of MKPs deliver unique, and in
some cases, non-obvious physiological and pathophysiological outcomes that has led to the realization that
MKPs represent valuable therapeutic targets for the treatment of certain diseases. We have found that MKP5,
which directly dephosphorylates p38 MAPK and JNK, is involved in the development of cardiac fibrosis, a
serious sequalae that precedes heart failure. Mice lacking MKP5 are protected from the development of
cardiac fibrosis and heart failure in a model of pressure overload. A high throughput small molecule screen
identified a first-in-class inhibitor of MKP5. Resolution of the co-crystal structure of the inhibitor in complex with
MKP5 revealed that the inhibitor bound to an allosteric site on MKP5. We hypothesize that the MKP5 allosteric
site represents an additional mode of MKP5 regulation that governs signaling specificity and that this allosteric
site represents the “Achilles heel” of MKP5 for small molecule targeting. The broad goal of this work is two-fold.
First, we will define the molecular basis for how the allosteric site regulates MKP5 catalysis and MAPK
signaling. Second, whether disruption of the allosteric site produces outcomes in a disease context that provide
proof-of-concept that if successfully “drugged” this site represents a platform for development of first-in-class
MKP inhibitors. We will execute the specifics of these two broad goals through three specific aims. Aim 1, will
employ structural biology and biophysical approaches to elucidate the structural determinants and binding
mechanisms conferred by the MKP5 allosteric site to determine how this site regulates MKP5 catalysis and
MAPK binding. A co-complex between MKP5 and p38 MAPK will be obtained to define how p38 MAPK
modulates MKP5 through the allosteric site. In Aim 2, the effects of mutants in the MKP5 allosteric site on
MAPK signaling will be determined by generating knockin cells harboring MKP5 allosteric site mutants using
CRISPR-Cas approaches. The specificity of the MKP5 allosteric site to “fine-tune” MAPK-mediated signaling
will be determined using non-biased phosphoproteomic and transcriptomic approaches. In Aim 3, the effects of
targeting the MKP5 allosteric site in cardiac fibrosis and heart failure will be determined through the generation
of a novel MKP5 allosteric site mutant knock-in mouse. These studies will define a new mode of operation for
MKP5 that will provide information on the actions of the allosteric site at the atomic level. How the MKP5
allosteric site impacts physiological signaling and the validity of the allosteric site as a “druggable” target in
disease therapeutics will be defined.

Public health relevance
NARRATIVE Cardiac fibrosis and heart failure have profound clinical impact on morbidity and mortality in the United States and worldwide. This project will take a multi-faceted approach to study a novel target of cardiac fibrosis by employing structural biology, chemical biology and genetic strategies. These findings will lead to new ways in which pharmacological intervention can be used as a treatment against heart failure.